Augmenting T-cell immunotherapy outcomes in blood and solid tumor microenvironment in ART-suppressed HIV infection (immune/microenvironment)

PROJECT SUMMARY
Persons living with HIV (PLWH) on effective antiretroviral therapy (ART) continue to exhibit residual immune
activation and inflammation as compared to HIV-negative individuals. This unresolved immune activation and
immune dysfunction is associated with sustained myeloid activation, sustained type I interferon signaling, and
an increase in co-morbidities such as adverse cardiac events or malignancies, especially in the aging PLWH
population. Indeed, PLWH that are suppressed on ART remain at an increased risk for developing Non-AIDS
defining cancers (blood and solid cancers), many of which are associated with a co-viral infection as the etiologic
agent. In the current era, immunotherapies aimed at reinvigorating or re-engineering the anti-cancer T-cell
immune response have the potential to revolutionize cancer treatment. Specifically, chimeric antigen receptor
(CAR) T cell therapies have been successful in treating certain B cell malignancies. However, until very recently,
PLWH have been excluded as candidates for CAR T cell therapy and other cancer clinical trials, largely due to
lack of prior clinical data and hurdles to GMP manufacturing. For solid cancers, the use of immune checkpoint
inhibition therapy (ICT) has been found to be safe in PLWH but whether reactivation of anti-cancer T-cell
responses can be sustained in the context of residual activation on ART remains unknown. For example, it has
been observed by several groups that inhibition of persistent type-I interferon after ART-suppression can
increase CD8 T-cell responses. As in CAR T cell trials, the exclusion of PLWH from the majority of clinical trials
testing emerging ICT strategies further adds to the lack of data on how residual activation within the tumor
microenvironment may affect the degree of anti-cancer T-cell activation. Based on our preliminary data, this
application will test the hypothesis that residual immune activation while on ART is mediated by elevated
expression of type I interferon (IFN-I) stimulated genes in the tumor microenvironment, and that this will adversely
affect the function of anti-cancer T-cell responses following CAR T-cell therapy or inhibition of immune check-
points. The first specific aim will evaluate the efficacy of CART19 immunotherapy against blood-based
autologous B cell malignancies and the impact of sustained type-I interferon signaling on the anti-cancer
response in HIV-infected, ART-suppressed humanized mice in vivo. The second specific aim will evaluate T-cell
infiltration and activation following anti-PDL-1 therapy against patient-derived solid tumors and the impact of
sustained type-I interferon signaling in anti-cancer response in HIV-infected ART-suppressed humanized mice in
vivo. Ultimately, the development of an animal model to identify barriers to activation of optimal anti-cancer T-
cell strategies following ART-suppression will provide an important resource to create more effective
immunotherapies for patients with HIV/AIDS-related cancers. This application is uniquely poised to address the
NIH OAR priority on how HIV may impact therapy outcomes for associated co-morbidities (e.g. malignancies).

Public health relevance
PROJECT NARRATIVE Research aims will address the impact of HIV infection on cancer immunotherapy strategies against blood and solid tissue cancers. The cord blood stem cell humanized mice model is used to study the interaction between HIV infection, viral suppression by antiretroviral therapy, cancer growth and immunotherapy.